Surgical Research Training in Gastrointestinal Diseases

PROJECT SUMMARY/ABSTRACT
The UTMB Department of Surgery T32 research training program provides state-of-the-art interdisciplinary
research training experiences for surgical residents interested in diseases of the gastrointestinal (GI) tract,
pancreas, and liver. Our central goal is to prepare our fellows to become productive, independent physician-
scientists and future leaders in academic surgical research. With this competitive renewal application, we are
requesting continued support to train three postdoctoral fellows per year. Our highly structured, degree-
granting curricula are designed to provide fellows with comprehensive foundational training in essential
scientific knowledge, methodologies, technical skills, and ethical considerations pertinent to the effective
practice of either basic and translational biomedical laboratory research or comparative effectiveness and
patient-centered outcomes research related to GI diseases. Since its inception, the program has trained 32
postdoctoral fellows. Of those who have completed their clinical training, 52% are currently in academic
surgery, and half of those have successfully competed for NIH funding. Trainees have been mentored by
faculty working at the cutting edge of scientific knowledge and utilized the most up-to-date technologies and
experimental approaches available to the field of GI disease research. Initially focused on the endocrinology of
gut peptide hormones and large animal models, today our program faculty study the GI microbiome and patho-
genic organisms, GI immunology, inflammation and tissue fibrosis, mechanisms of GI tissue normal growth,
injury repair, and carcinogenesis, epidemiology and clinical outcomes research. They use genetically modified
rodent models, multiple cell-type culture systems, the latest omics technologies and bioinformatics
approaches, high resolution molecular imaging, advanced molecular and cellular separation technologies,
sophisticated gene editing and expression methods, recombinant DNA, microRNA and reporter gene assays,
adaptive cellular transfer procedures, epigenetics, and state-of-the-art methods to isolate, analyze and culture
tissue- and disease-specific microbiomes. Our highly collaborative and productive faculty mentors (with 550
publications in the past 5 years, and over $23 million in current grant funding) represent 9 UTMB departments
(5 clinical / 4 basic science). This multidisciplinary training environment has fostered the productivity of our
fellows, who have published a total of 85 scientific papers (average of 6 papers/fellow; 2.8 first author publica-
tions) in the past 10 years. Our strong track record stands as evidence for our success in recruiting minorities
and women into our training program. In the past 10 years, 60% have been women and 40% also identified as
an underrepresented minority. In summary, we have established a robust record of achievement by preparing
our fellows to become productive, independent physician-scientists and future leaders in academic surgical
research. With further support from the NIH and NIDDK, we will continue our rich history of success and meet
the ever-growing need to prepare well-trained physician-scientists to enter the biomedical workforce.

Public health relevance
PROJECT NARRATIVE The need for well-trained surgeon-scientists who possess the knowledge and skills to advance new discoveries into improvements in the diagnosis, care and treatment of surgical patients with gastrointestinal (GI) diseases has never been greater. The University of Texas Medical Branch Department of Surgery T32 research fellowship program is focused on providing state-of-the-art interdisciplinary research training experiences for surgical residents interested in diseases of the GI tract, pancreas, and liver. Our highly structured, degree-granting curricula provide fellows with the comprehensive foundational scientific knowledge, methodologies, technical skills, and ethical considerations needed to solve the surgical healthcare challenges of the 21st century.